Degradation and Fatigue Behavior of 3D Printed Bioresorbable Tracheal Splints

? DESCRIPTION (provided by applicant): Tracheobonchomalacia (TBM) is a congenital or acquired deficiency of tracheal and/or bronchial cartilages that presents with dynamic airway collapse, respiratory difficulties, and, in severe cases, acute life-threatening events. TBM prevalence is estimated at 1 in 2,200 children1, and severe cases can result in death or require tracheostomy with ventilation for 2-3 years, a significant burden on the child and family2,3. We recently developed a bioresorbable, patient specific 3D printed polycaprolactone (PCL) splint to treat TBM, reporting the first case in the New England J. of Medicine4. Two subsequent children with life threatening TBM were saved with the splint and the first child continues to be asymptomatic 30 months post-surgery. Based on these results, we met with the FDA on August 22, 2014 to initiate a phase I clinical trial for Humanitarian Device Exempt (HDE) approval. These preclinical questions dealt with the degradation mechanisms and fatigue behavior of the splint, how splint design and 3D printing orientation affect splint degradation and fatigue, and how the splint affects airway mechanics over time with degradation. We will address these questions in two specific aims using both in vitro and in vivo preclinical model, the Yorkshire pig The first aim will characterize splint degradation both in vitro and in vivo for up to 2 years. The second aim will use this data to characterize how the splint affects airway mechanics.

Public health relevance
PUBLIC HEALTH RELEVANCE: Tracheobronchomalacia (TBM) is a congenital or acquired deficiency of tracheal and/or bronchal structures resulting in partial or complete collapse of tracheal and/or bronchal segments. TBM presents with dynamic airway collapse and respiratory difficulties. In severe cases, TBM results in acute life-threatening events and even death. We have developed a bioresorbable splint for TBM that can be custom designed for patient specific anatomy and custom designed to have specific mechanical properties. The splint is fabricated using a 3D printing process which we have developed for bioresorbable PCL. We are currently going forward with plans to perform a clinical trial on the splint. As part of this, we and the FDA saw a need for more preclinical data on long term splint degradation and how this degradation affects splint and airway mechanics. We will evaluate degradation both in vitro and in a large in vivo preclinical model, the Yorkshire Pig. We will further perform finite element modeling of malacic airways with the splint to determine how degradation affects mechanical stimulation of the airway.